A rapid, culture-free whole genome approach for characterizing complex metagenomics samples

Project Summary / Abstract Dovetail Genomics has adapted our in vitro proxity-­ligation method for fecal metagenomics applications. We are developing a powerful and efficient approach to de novo metagenomics assembly that will allow the research and biomedical communities to move beyond single locus molecule counting or statistical inference. Successful development of this approach will provide a single, integrated workflow for accurate assembly of all major constituents of complex metagenomics communities. This tool will enable a comprehensive understanding of the ways our gut microbiome influences human health and disease. In this project, Dovetail Genomics will develop the modifications to the laboratory procedures necessary to efficiently capture and represent the diversity of microbes present in a human fecal sample. We will also modify and develop a new computational approach to metagenomics assembly that exploits the rich datatype that we generate. This computational approach will achieve highly contiguous scaffolding and strain deconvolution. We envision a robust, fool-­proof laboratory protocol and software product that allows a clinician to generate a comprehensive view of the dynamic human gut microbial environment from a small fecal sample in a manner of days.

Public health relevance
Project Narrative Many aspects of human health and fitness are impacted by the rich microbial communities in our gastro- intestinal tracts. Dovetail Genomics is developing a simple and powerful approach to revealing the full genomic complexity of this community. This tool will allow the research and biomedical communities to quickly, accurately, and quantitatively assay the full genetic repertoire present in the human gut.